Novel screening platform for O-GlcNAc transferase substrate-specific inhibitors to combat aging-related diseases

Project Summary
The O-linked β-N-acetylglucosamine (O-GlcNAc) is an essential post-translational modification
found in thousands of proteins involved in a broad range of important biological processes,
including epigenetics, metabolism, and protein degradation. The O-GlcNAc modification is
dynamically added and removed by a single pair of human enzymes, O-GlcNAc transferase
(OGT) and O-GlcNAcase (OGA), respectively. Dysregulation of O-GlcNAcylation has been
detected in many aging-related diseases including cancer, diabetes, Alzheimer’s and
Huntington’s disease. To date, several effective active-site inhibitors have been reported for OGT
and OGA, but they are likely to induce undesired side effects as these essential enzymes regulate
O-GlcNAc dynamics on thousands of protein substrates. Currently, there is no report on
substrate-specific inhibitors of OGT or OGA, largely due to the lack of suitable assays. Here, I
propose to develop a novel high-throughput screening assay for identifying small molecules that
can specifically bind to different regions of OGT and modulate O-GlcNAcylation of a particular
protein of interest without perturbing the global O-GlcNAc level in cells. From the proposed screen
and the following in vitro and cellular characterization and optimization processes, I expect to
identify several compounds as the first generation of substrate-specific inhibitor candidates of
OGT that can modulate O-GlcNAcylation on particular proteins related to aging diseases. This
new assay platform can be potentially adapted for other protein substrates and facilitate the
therapeutic development to combat aging disorders.

Public health relevance
Project Narrative O-GlcNAcylation is a unique type of protein modification and its dysregulation has been implicated in many aging diseases including cancer, Alzheimer’s and Huntington’s disease. The human enzyme O-GlcNAc transferase (OGT) catalyzing the addition of this modification on thousands of proteins is a potential new drug target, but developing specific inhibitors to target this essential enzyme without inducing global side effects is very challenging. I propose to develop a novel assay platform for identifying small-molecule compounds that specifically inhibit OGT toward a particular protein substrate of interest without perturbing global O-GlcNAcylation to facilitate the therapeutic development against aging diseases.